Stigma Intervention Core

Project Summary/Abstract
The Intervention Core has a unique opportunity to greatly enhance the value of stigma and HIV intervention
research at JHU and Emory by implementing programs and establishing structures that foster collaborations
across a range of domains: junior and senior faculty; behavioral and biomedical prevention researchers;
prevention and treatment researchers; researchers in public health and other schools and departments within
JHU and Emory. While there several biomedical and behavioral interventions addressing HIV prevention and
treatment at JHU and Emory, there is a limited awareness and availability of evidence-based interventions
focused on stigma and structural determinants of HIV using appropriate study designs. To date, there is no
formal academic institutional structure that: (1) provides investigators with access to expertise in stigma and
HIV interventions, (2) offers foundation in the development and evaluation of stigma and HIV interventions, (3)
assists investigators with harnessing the full potential of innovative stigma and HIV interventions, and (4)
utilizes the guidance and expertise JHU and Emory investigators implementing stigma and HIV interventions.
We propose mechanisms through which an Intervention Core would establish a culture that clearly values the
goals of supporting investigators, training and collaboration and interdisciplinary research while providing an
infrastructure to facilitate these goals. Particularly, the Intervention Core aims to: Aim 1: Facilitate productive
collaborations between JHU and Emory intervention scientists and community organizations and encourage
investigators without prior intervention research experience to collaborate with Core-affiliated stigma and
HIV/AIDS intervention researchers. The core will link trainees and junior JHU and Emory faculty to Intervention
Core-affiliated investigators as mentors, link faculty to Intervention Core-affiliated community organizations as
collaborators, offer guidance in study design, implementation, and analysis from researchers in the Intervention
Core, provide opportunities to gain knowledge in intervention research through an Intervention Core Fellows
program and an annual training symposium, and facilitate interdisciplinary collaboration opportunities by
providing regular intervention research updates, international and domestic conferences, and community-wide
town hall meetings. Aim 2: Foster expansion of the Maryland, Georgia, and international intervention research
base at JHU and Emory by increasing access to scientific services in support of stigma and HIV researchers.
Achieved by Facilitate access to faculty expertise in intervention research through an Intervention Core
Consulting Service which will link experts and community organizations with faculty, students, and community
organizations interested in engaging in this research area. Provide training on the development of
effectiveness and implementation studies addressing stigma and HIV through didactic webinars, experiential
learning, and intervention design and analytical assistance. Create and maintain an accessible repository of
evidence-based stigma and HIV intervention frameworks, study designs, and other research tools.